Epigenomic analysis of cell-free nucleosomes for cancer research

PROJECT SUMMARY
Cell-free DNA (cfDNA) levels are elevated in cancer patients, driving a rising interest in liquid biopsy (LB)-
based assays for cancer research. However, current cfDNA assays (which assess the abundance, sequence,
and/or methylation status of cfDNA) have limited ability to differentiate cell types and disease states for
diagnostics and disease monitoring. Of note, cfDNA is primarily found as nucleosomes (cfNucs). Chromatin
features including histone post-translational modifications (PTMs) on nucleosomes play key roles in gene
regulation, and analysis of these features can inform tissue of origin and disease states. Thus, analysis of cfNucs
can provide important information that is lacking from current cfDNA assays. Early applications of cell-free ChIP-
seq (cfChIP-seq) have demonstrated the potential of this approach to reveal disease-associated transcriptional
programs and drug targets. However, commercial ChIP-seq assays have not yet been optimized for cfNuc
analysis, and the ChIP-seq field is fraught with issues including poor sensitivity, cross-reactive antibodies, and
lack of standardized controls. To fully leverage LB for clinical applications, there is a need for development of
new epigenomic assays that have the sensitivity and reliability to resolve cancer biomarkers from human plasma.
EpiCypher is developing cfNuc-seq™, the first commercial platform for epigenomic profiling from human
plasma samples. cfNuc-seq assays will be quantitative (enabling reliable cross-sample comparisons), sensitive
(able to detect disease signatures from limited inputs), and specific (on-target signal, ability to distinguish distinct
disease states). A key innovation of this proposal is the application of ultra-affinity detection reagents to develop
a highly sensitive and specific cfChIP-seq workflow to quantitatively compare cfNuc profiles across disease
states. A second key innovation is the incorporation of DNA-barcoded designer Nuc (dNuc) spike-in controls to
enable in-assay assessment of antibody specificity as well as technical monitoring, normalization, and
quantitative cross-sample comparison. Notably, the development of highly sensitive and standardized assays
for LB sample analysis is essential due to the low and variable abundance of cfNucs across patients and disease
states. Overall, cfNuc-seq assays will be the first commercial epigenomic profiling assays specifically optimized
for human plasma, providing ready-to-use assays for easy adoption by clinical researchers. In Phase I, we
established strong proof-of-concept by identifying high-performance antibodies and applying them to distinguish
cancer-specific signatures in human plasma-based cfNuc-seq assays (with a limit of detection of <0.1%). In
Phase II, we will perform essential development to enable commercialization of cfNuc-seq assay kits and
services for cancer (pre)clinical research. We will first develop and optimize cfNuc-seq assays for multiple high-
value targets (Aim 1). Next, we will perform robust assay validation and develop a bioinformatic pipeline to
facilitate deconvolution of cancer signatures from heterogenous samples (Aim 2). Finally, we will prepare for
commercialization by assembling beta-kits and performing validation using real-world clinical samples (Aim 3).

Public health relevance
PROJECT NARRATIVE Existing liquid biopsy assays focus on analysis of abundance, sequence, or methylation of cell-free DNA, which reveal limited insights for cancer diagnostics or monitoring. Analysis of chromatin features on cell-free nucleosomes has greater potential for clinical research by providing more information on transcriptional regulatory programs that drive disease. Here, we will develop novel assays for ultra-sensitive, quantitative epigenomic profiling from human plasma samples, spearheading a major advancement in noninvasive chromatin analysis for cancer research and diagnostics.